Core H: Systems Immunology

PROJECT SUMMARY/ABSTRACT
The Emory CFAR Systems Immunology (SyImmun) Core (Core H) enables studies of the pathogenesis,
treatment, and prevention of immunodeficiency virus infections in humans and nonhuman primates by providing
access to state-of-the-art tools for the study of immunological function. There is a growing need for the
application of advanced techniques that expand the HIV research community's ability to better understand
immune cell function particularly given recent advances in high-dimensional analytic tools for the analysis of
immune responses, including single cell RNA-Seq (scRNA-Seq) and related multi-omic techniques. The
SyImmun Core comprises three Units: 1) Flow Cytometry; 2) Single Cell Multi-omics, and 3) Systems
Immunology Training. The Core has an outstanding track record of providing CFAR Members with training,
education, and a full range of services, including state-of-the-art polychromatic analytic flow cytometry and cell
sorting, along with an array of analytic tools. Drawing on considerable expertise of Core leadership, the
SyImmun Core will provide an array of high-throughput multi-omic single cell profiling techniques, including
scRNA-Seq, CITE-Seq (Cellular Indexing of Transcripts and Epitopes, which allows integration of single cell
transcriptomic and proteomic data), and single cell ATAC-Seq, which allows single cell epigenetic analysis.
Training will be provided to investigators on the design of flow cytometric and single cell multi-omic
experiments, along with a suite of courses that provide introductory and intermediate level courses in analytic
tools used for the analysis of these data sets. Bioinformatic and biostatistical support and analytic tools will also
be provided through the Core. The Systems Immunology Core proposes the following specific aims:
Aim 1: Provide the highest quality flow cytometry data, cell sorting services, and analytic tools to Emory CFAR
Members in support of groundbreaking Immunology research;
Aim 2: Support an array of single cell multi-omics techniques, including scRNA-Seq, CITE-Seq and ATAC-Seq
and outstanding bioinformatic and biostatistical expertise in collaboration with the Biostatistics and
Bioinformatics Core;
Aim 3: Train CFAR Members in the state-of-the-art design and analysis of flow cytometric and single cell multi-
omic techniques. These services will provide Emory CFAR Members with unprecedented access to a wide
range of tools in support of groundbreaking research to better understand immune function in HIV and SIV
infection, and to further develop novel approaches to prevent and cure HIV infection.